Uncovering the mechanism of virulence factor maturation in Haemophilus influenzae

Project Summary/Abstract
Non-typeable Haemophilus influenzae (NTHi) is a bacterial pathogen that infects the lower
airways and is the main pathogen responsible for exacerbations of chronic inflammatory
pulmonary disease (COPD). COPD affects 6.4% of American adults and is the fourth leading
cause of death worldwide. Due to the persistent nature of NTHi, antibiotic resistance is increasing
and new therapeutic strategies are needed. Recently, a new virulence factor termed NTHI1441
was discovered through genome mining efforts. This protein is expressed as part of the
NTHI1440-1444 operon that contains the putative biosynthetic genes NTHI1443 and NTHI1444,
which show homology to DUF692- and DUF2063-family proteins, respectively. Homologous
operons, such as the methanobactin biosynthesis operon identified in methane-oxidizing bacteria,
encode a ribosomally synthesized post-translationally modified peptide (RiPP) natural product
precursor and biosynthetic DUF692- and DUF2063-like proteins that form a complex to modify
the RiPP precursor peptide. Thus, I hypothesize that the NTHI1441 gene encodes a RiPP
precursor peptide that is post-translationally modified by NTHI1443 and NTHI1444 to
generate the mature virulence factor. The goal of this research proposal is to uncover the
molecular details of the maturation, structure, and function of the virulence factor using in vivo
and in vitro approaches. In Aim 1, the biochemical properties of the biosynthetic proteins will be
examined using spectroscopic, structural, and biophysical techniques. Aim 2 involves a mass
spectrometry-based proteomics approach to characterize the post-translational modifications
(PTMs) conferred to the peptide substrate as produced by combinatorial heterologous expression,
in vitro reconstitution, and isolation from the native organism NTHi to provide a detailed
understanding of the molecular structure and biosynthesis of the mature virulence factor. Finally,
in Aim 3, genetic knockouts of the biosynthetic proteins in NTHi will be constructed and used for
invasion assays to assess whether the PTMs are essential for NTHi virulence. The outcomes of
this project will provide insight into the highly conserved yet underexplored DUF692-family of
biosynthetic proteins and will also illuminate the structure and function of a key virulence factor,
which will establish the foundation for the development of targeted therapeutics to treat NTHi
infections.

Public health relevance
Project Narrative Non-typeable Haemophilus influenzae is a bacterial pathogen that causes lung and ear infections and severe exacerbations in individuals with chronic obstructive pulmonary disease. This project will uncover the post-translational modifications and function of a recently identified virulence factor that plays a significant role in human cell invasion during infection. Understanding the molecular details by which this virulence factor functions will provide opportunities for development of new therapeutics.